Lipid droplets as protein sequestration sites

Project summary
Lipid droplets are the intracellular sites for fat storage, with essential functions in lipid metabolism and energy
storage. They also have a second major role in controlling the fate of specific proteins, namely mediating their
maturation, transport, refolding, storage, and turnover. While there has been great progress in unraveling how
droplets control lipid metabolism, studies of their protein-handling roles remain limited. The goal of this project
is to dissect the mechanism, regulation, and physiological relevance of this protein handling function, by taking
advantage of the best characterized example of this phenomenon, the sequestration of histone H2Av to lipid
droplets in Drosophila ovaries and embryos. H2Av is dynamically stored, exchanging constantly between lipid
droplets via the cytoplasm. Lipid droplet sequestration prevents H2Av degradation in oocytes and its premature
import into nuclei in embryos. It is also developmentally regulated, being switched off in embryos at the mid-
blastula transition. Progress in the last granting period identified the importins Impa2 and Ipo9 as critical
factors mediating H2Av exchange, uncovered a correlation between the activity of the cell cycle kinase Cdk1,
the phosphorylation state of Impa2, and the rate of H2Av exchange, and discovered that excess nuclear H2Av
dramatically alters the transcriptome. These insights led to new models about the mechanism of H2Av
exchange, its regulation, and its biological role, models that the current application proposes to test. It is
hypothesized that Impa2 promotes H2Av exchange by physically interacting with Jabba and reducing its
affinity to H2Av and that Ipo9 acts as cytoplasmic chaperone, accompanying H2Av on its journey between
LDs. This model will be tested by determining intracellular distribution and dynamics of the two importins in
ovaries and embryos and by analyzing how mutants in key functional domains affect H2Av exchange. To
understand the developmental regulation, point mutants in Impa2 will be generated to prevent or mimic
phosphorylation and Cdk1 activity will be inhibited. The consequences of these manipulations for H2Av
exchange and the physical interactions between importins, the H2Av anchor Jabba, and H2Av will be
determined. In nurse cells lacking Jabba, absence of sequestration results in increased levels of nuclear H2Av.
Using RNA seq analysis, manipulation of H2Av dosage, and Jabba mutants unable to bind H2Av, it will be
determined whether the altered H2Av levels result in changes to the transcriptome. If successful, these studies
will test key predictions about the mechanism, regulation, and function of H2Av sequestration by lipid droplets
and develop general paradigms for how protein handling by lipid droplets can control processes elsewhere in
the cell. These studies will thus provide the groundwork for determining if and how protein sequestration by
lipid droplets contributes to their prominent roles in health and disease.

Public health relevance
Project narrative Lipid droplets are cellular organelles that store fat and are misregulated in many human diseases. They also have a major function in protein handling, including for certain viral and nuclear proteins. This project analyzes how lipid droplets exchange proteins between each other, how cells turn this exchange on and off, and how it affects cellular function, potentially uncovering new principles of how lipid droplets promote health and disease.